Targeting Cysteine Susceptibility in Glioblastoma

Project Abstract
Glioblastoma (GBM) is one of the most lethal human cancers. Standard GBM treatments, such as radiation
(RT) and temozolomide (TMZ), exhibit poor efficacy with a lack of a durable response. These agents promote
oxidative stress in cancer cells, which is a known metabolic liability of GBM. However, the efficacy of these
treatments is limited by neurotoxicity and upregulation of tumor escape pathways that detoxify reactive oxygen
species. There is an urgent need for new pharmacological agents that effectively target the redox stress
pathway in GBM cells while sparing adjacent normal tissue. My long-term goal is to become an independent
physician-scientist neuro-oncologist focused on improving GBM therapy. In this proposal, I use my discovery
of a cysteine susceptibility pathway in glioma, whereby cysteine-promoting compounds induce glucose
dependence, mitochondrial toxicity, and H2O2 production, to define the mechanism and functional relevance
of this pathway in pre-clinical models. I will test the central hypothesis that high levels of intracellular cysteine
induce glucose dependence in glioma, and the combination of cysteine compounds with ROS-promoting
treatments is an effective strategy to improve survival in mouse models of GBM. I will identify the metabolic
flux pathways altered by cysteine in glioma (Aim 1a) and determine the role of mitochondrial electron transport
chain flux (Aim 1b) and hypoxia and glycolytic flux (Aim 1c) in contributing to cysteine-mediated glucose
dependence. Using mouse models of GBM, I will test the efficacy of cysteine compounds in combination with
ROS-promoting interventions (RT, TMZ, and the glucose-lowering ketogenic diet) on GBM metabolism, growth,
and survival, using 18F-fluoropropyl-homocysteine positron emission tomography as a biomarker for cysteine
metabolism (Aim 2a). I will determine the effects of H2O2 modulation on cytotoxicity of cysteine compounds
and ROS-promoting interventions (Aim 2b) in vivo. These aims will create a new paradigm that uses two
synergistic metabolic therapies that can be rapidly translated into early-phase clinical trials in GBM. I am an
Assistant Professor in Neurology within the Division of Neuro-Oncology at Weill Cornell Medicine (WCM), and
I have outlined a 5-year plan that expands on my background studying GBM metabolism. I have an outstanding
mentor, Dr. Lewis Cantley, who is an expert in tumor metabolism and has enabled translation of his work and
mentees’ work to clinical development. My career advisory committee includes Drs. Lewis Cantley (primary
mentor), Navdeep Chandel, Pedro Lowenstein, Naga Vara Kishore Pillarsetty, Howard Fine, and Matthew
Fink. They are internationally recognized experts in science and medicine and will provide mentorship and
support to attain scientific independence. I will also have unparalleled institutional support from WCM, which
is at the forefront of precision medicine in cancer and is heavily invested in career development for junior
physician-scientists. This research and training environment will enable me to achieve my goals of securing
NIH R01 funding in the future.
1

Public health relevance
Project Narrative Metabolism of glucose and amino acids is critical to the growth of many cancers, including glioblastoma, but treatments to target tumor metabolism remain under-studied. I have identified a susceptibility pathway to the amino acid, cysteine, in glioblastoma, and treatment of glioblastoma cells with cysteine compounds causes glioblastoma cell death, particularly in the setting of glucose deprivation. The proposed research will define the mechanism by which cysteine induces glucose dependence and will use animal models of glioblastoma to validate the use of cysteine therapy combined with a very low carbohydrate (ketogenic) diet as well as radiation and chemotherapy for glioblastoma. 1